Molecular Basis for the TREX-2 mRNA Nuclear Export Pathway

Project Summary
Nuclear export of mRNAs through the nuclear pore complex (NPC) is an obligatory pathway for eukaryotic gene
expression, which is regulated by various cellular stress conditions such as viral infections and immune
responses. During gene expression, the TREX (TRanscription and EXport) complex is recruited co-
transcriptionally and pre-mRNA processing further mediates TREX assembly on the transcript. Through the
combined action of the TREX complex and other mRNA export factors, the major mRNA export receptor NXF1-
NXT1 heterodimer is recruited to the mRNA. At the nuclear face of the NPC, NXF1-NXT1 bound to mRNA can
either dock at the NPC or associate with an NPC-anchored complex termed TREX-2 (TRanscription and EXport
2) complex, enabling docking and translocation of mRNAs through the NPC. We and others have shown that
the TREX-2 complex mediates nuclear export of a large subset of cellular mRNAs, among which are mRNAs
that
encode histone modifying enzymes and RNA processing factors, and influenza virus mRNAs. Additionally,
we identified an RNA signal that can determine TREX-2 dependency. However, the molecular mechanisms
involved in the functions of TREX-2 and the role of new constituents of the complex in the mRNA nuclear export
pathway remain to be elucidated. Here, we will use interdisciplinary approaches including cell biology,
biochemistry, and structural biology to pursue two extensive aims. In Aim 1, we will elucidate the differential role
and interaction network employed by TREX-2 and a new form of the complex, TREX-2LENG8, to mediate nuclear
export of cellular and influenza virus mRNAs. Additionally, we will investigate the RNA-protein interactions that
determine TREX-2 or TREX-2LENG8 dependency. Thus, the findings from these studies will establish the
molecular mechanisms by which TREX-2 or TREX-2LENG8 mediates recruitment and nuclear export of cellular
and influenza virus mRNAs. In Aim 2, we will determine the structural and functional basis for the cellular NS1-
BP protein in the TREX-2 mRNA export pathway. We have identified a network of interactions and potential
mechanisms involving NS1-BP, NXF1-NXT1, and TREX-2 that mediate nuclear export of an important subset of
cellular and influenza virus mRNAs. The latter also requires the viral NS1 protein. We will determine the structural
basis for the established interactions and investigate their molecular mechanisms and functional significance
within the TREX-2 mRNA export pathway. Moreover, we will systematically identify and characterize the cellular
mRNAs that require NS1-BP for nuclear export and investigate the functional significance of NS1-BP interactions
with NXF1-NXT1 and TREX-2 for nuclear export of these NS1-BP dependent mRNAs. Collectively, our studies
will reveal fundamental knowledge on the role of the TREX-2 complex in mediating nuclear export of mRNAs,
which impact a large subset of cellular mRNAs and influenza virus mRNAs. Additionally, the findings on the
interaction between the influenza virus NS1 protein and the TREX-2 complex could be potentially used for
designing antiviral strategies to inhibit influenza mRNA nuclear export and, consequently, viral replication.

Public health relevance
Narrative Messenger RNAs (mRNAs) are generated in the cell nucleus and are then exported to the cell cytoplasm for translation into proteins. These studies address novel functions of an mRNA nuclear export process termed the TREX-2 pathway, which exports a large subset of cellular mRNAs and influenza virus mRNAs. As influenza virus pandemics are recurrent and the next pandemic is becoming a major concern, knowledge of these mechanisms that are key for influenza virus gene expression could be potentially used for designing therapeutic strategies.